The Neural Mechanisms of Motor Dysfunction in Clinical High-Risk Youth.

Project Summary
Motor abnormalities are a core feature of schizophrenia that are present across all phases of the illness from the
premorbid stage (i.e., pre-illness) to chronic psychosis. Consistent with a dopamine (DA) etiological
conceptualization of psychosis, aberrant motor function across the different phases of the disorder is both
associated with abnormal structural and functional dopamine mediated motor circuitry and predicts
conversion. However, to date, the majority of research examining motor dysfunction in psychosis has focused
on overt motor performance (e.g., video coded movement abnormalities) in patients with schizophrenia.
Because of this, little is known about the timing of neural processes underlying abnormal motor behavior in
schizophrenia, and there has been no work conducted in youth in the clinical high-risk (CHR) period of the
disorder (the stage immediately preceding the first episode of psychosis). Given that both motor planning and
motor execution arise from underlying dopamine (DA) mediated motor circuitry implicated in the
pathogenesis of the illness, understanding how these mechanisms are impaired before the onset of the
disorder (i.e., in CHR populations) stands to inform our understanding of the etiology of psychosis, as well as
provide a putative vulnerability marker sensitive to progression. The current proposal will address these
questions using a longitudinal investigation of neural abnormalities in motor planning and execution (Aim 1)
in CHR youth and healthy controls. The individual processing stages underlying motor planning and
execution will be measured using a combination of the lateralized readiness potential ERP component and
behavioral reaction time (RT) variability (i.e., standard deviations of RT). The neural measures in Aim 1 will be
validated against behavioral motor measures (i.e., dyskinesias) known to reflect abnormal DA mediated motor
circuitry (Aim 2). To track clinical progression and risk, associations between the measures from Aim 1 and
symptom severity, symptom progression, and psychosis risk will be examined (Aim 3). Training Plan: An
extensive training plan has been developed to enable the Applicant to effectively complete the project.
Through coursework, colloquia/conference attendance, workshops, and weekly meetings with the sponsors,
the Applicant will develop theoretical expertise in motor pathology in psychosis, as well as specialized skills in
the ERP technique and longitudinal research design. This training plan was designed to facilitate the
Applicant’s career aspirations as a research scientist with the sound theoretical foundation and methodological
expertise necessary to conduct his own independent program of research. Training Environment: The project
will take place at Northwestern University, an ideal training environment given the accessibility to cutting-
edge resources, equipment, and coursework at the site. Further, both the Sponsor and Co-Sponsor are located
at the institution and are experts in the theory and methods needed to meet the Applicant’s training aims.

Public health relevance
Project Narrative The onset of schizophrenia (a chronic, debilitating mental illness) typically occurs in late adolescence and early adulthood, resulting in significant impairment when young adults first begin transitioning into more demanding and independent social and occupational roles. Although research has advanced our basic knowledge of the illness, the pathogenic processes that give rise to psychosis are not well understood, making the development of markers sensitive to disease progression a priority for the field. Current research indicates that motor abnormalities may be a promising biomarker for schizophrenia spectrum disorders; elucidating the neural mechanisms underlying motor abnormalities in individuals exhibiting a prodromal syndrome (i.e., those at clinical high-risk for the disorder) stands to inform our understanding of the etiology of the illness, as well as improve efforts in early intervention and preventative treatment.